Early Life Phenotyping of Very Preterm Infants

PROJECT SUMMARY/ABSTRACT
In the United States, over 60,000 infants are born very preterm (VPT, ≤32 weeks’ gestation) each year; more
than 15% of these infants die in infancy, while ~20% survive with severe morbidity. Despite the sobering
statistics, not all preterm infants face these consequences. A crucial factor in determining outcomes is the
individual infant's response to any given therapy. However, our understanding of factors causing variation in
response, beyond immaturity itself, is limited and impedes our ability to customize therapies. The perinatal
period, is a critical time window when multiple changes and adaptations in the fetus/newborn set the foundation
for the future. Perinatal events could therefore be important determinants of variation in later life health and could
be used to identify therapeutically relevant phenotypes. Previous phenotyping efforts in preterm birth have either
based the categorization on the presentation leading to preterm delivery (aimed at prevention of preterm birth);
or used neonatal severity of illness markers (aimed at mortality prediction); or made prediction models for specific
complications (aimed at improving management of said morbidity). These approaches intentionally exclude
perinatal interventions such as delivery mode and perinatal antibiotics to minimize impact of practice variation.
However, maternal care practices are critical exposures that affect the infant’s response to interventions. Our
central hypothesis is that perinatal variables combining reason for birth with intrapartum care variables and
neonatal presentation can be used to categorize infants into finite ‘phenotypes’ early in life and can explain
variation in multiple later health outcomes. In aim 1, we will use a novel conceptual model to create perinatal
phenotypes by integrating the variables using clustering techniques. In aim 2 and 3, we will determine the
contribution of perinatal variables in explaining the variation of 2 key outcomes: timing and type of late-onset
infection and abnormal growth trajectory. In experimental models, both late-onset infection and weight gain are
causally linked with early-life colonization, which, in turn, is influenced by multiple perinatal factors. Thus,
perinatal factors, and any derived phenotypes from these factors, may explain the risk variation for these
outcomes. To perform this study, we will leverage a unique registry of over 3600 very preterm infants and their
mothers with manually adjudicated reason for birth and in-patient neonatal course, that we can link with
longitudinal pediatric records from birth to 5 years. The study team and PI have extensive experience in modeling
perinatal variables, creating linked datasets, clustering techniques and expertise the field of preterm birth and
neonatal infections. The expected result of our study is to create a much-needed and novel patient selection
framework for early life interventions, specifically those targeting early colonization, infection and inflammation.
If successful, such a framework could change the paradigm of how trials are designed and ultimately how clinical
care is customized.

Public health relevance
PROJECT NARRATIVE Among very preterm infants, variation in health outcomes within gestational age categories may be explained by perinatal factors. We propose to define a perinatal phenotype for very preterm infants that integrates maternal characteristics and care with infant presentation at birth to predict meaningful outcomes.